Neighborhood characteristics and neurodevelopment: Risk and protective factors, and susceptibility to stressors and school disruption during the COVID-19 pandemic

Project Summary
Neighborhoods are an important ecological context for child and adolescent development and a social
determinant of physical health, mental health, and school achievement. Research has begun to elucidate the
associations between neighborhood disadvantage and brain structure, function, and behavior in relation to
executive function (EF) emotion regulation (ER), and emotional processing which may contribute to these short-
and long- term differences in health and development. Nevertheless, there are no population-based studies that
have examined the relation between neighborhood disadvantage, and changes in neighborhood disadvantage,
with longitudinal changes in neurodevelopment to determine if differences widen, narrow, or remain stable during
adolescence, a potential sensitive period. Moreover, there has been limited consideration of how associations
may vary across the country, and thus if they are of widespread importance. In addition, neighborhood risk may
increase vulnerability to major stressors and disruptions in schooling, such as during the COVID-19 pandemic.
These COVID-19 related changes have disproportionately impacted disadvantaged communities and may
exacerbate neighborhood-related differences in underlying neurodevelopmental systems. Finally, it is important
to understand resilience, and the modifiable contextual factors that may protect against both neighborhood
disadvantage and the impact of COVID-19. This proposal will use the Adolescent Brain and Cognitive
Development (ABCD) Study, an ongoing longitudinal study that is uniquely suited to address these questions.
The ABCD Study enrolled a diverse cohort of 9-10-year-old children (n = 11,878) across 21 U.S. sites, contains
multimodal measures of neurodevelopment for EF, ER, and emotional processing and rich measures of family,
school, and neighborhood contexts, as well integrated rapid measurement of COVID-19 related impacts. This
study will capitalize on the staggered timing of the pandemic onset in the ABCD cohort, which occurred between
varying waves of data collection across participants. This creates a quasi-experimental design with the study
separated into a pre-pandemic and post-pandemic onset phase. In the pre-pandemic phase, we will determine
the association between neighborhood disadvantage, and neighborhood change, with longitudinal change in
brain and behavioral development (Aim 1). Second, we will examine if the COVID-19 pandemic, and associated
stressors and school disruptions, are associated with brain and behavior change, and exacerbate neighborhood
related differences, with pre-pandemic measures serving as controls for post-COVID-19 measures. (Aim 2).
Finally, we will elucidate the modifiable family, community and school factors that serve as moderators and foster
resilience (Aim 3). This study will thus identify potential neurodevelopmental pathways related to neighborhood
disadvantage and COVID-19, and identify modifiable contextual factors that are potential targets for policy and
programmatic interventions to ameliorate disparities in health and well-being, and the disparate impact of
COVID-19, while informing prevention strategies for subsequent pandemics or disasters.

Public health relevance
Project Narrative Although recent research has found that neighborhood contexts are associated with brain structure, function, and behavior in relation to executive function (EF) and emotional functioning, central questions remain as to the role of neighborhoods in developmental change in these systems during adolescence, whether neighborhood disadvantage may also increase vulnerability to the stress and school disruption of the COVID-19 pandemic, and the modifiable contextual factors that may protect against adversity and foster resilience. The proposed study will capitalize on the longitudinal Adolescent Brain and Cognitive Development (ABCD), as well as the staggered onset of the pandemic across waves of data collection in ABCD, which creates an innovative quasi- experimental design to address these questions. This study will thus identify potential neurodevelopmental pathways related to neighborhood disadvantage and COVID-19 as targets for intervention as well as modifiable contextual factors that can inform immediate policy and programmatic interventions across disciplines and the prevention of long-term sequelae and disparities for subsequent pandemics or disasters.